Translational and Genomic Pediatric Cancer Epidemiology Training Grant

Abstract
The University of Minnesota Department of Pediatrics and Masonic Cancer Center propose to continue a
highly successful training program in translational and genomic pediatric cancer epidemiology research. Our
program is sought nationally ‐by scholars, and provides opportunities for 1 predoctoral and 3 postdoctoral
students to enhance their research and experience across a spectrum of pediatric cancer research, with a
goal of interdisciplinary cross training. With 19 outstanding mentoring faculty, trainees work in a variety of
research settings including classical epidemiology, genomic epidemiology, laboratory studies, and clinical
investigations. Along with seminars specific to pediatric cancer, strong graduate school degree programs at
the University of Minnesota in Epidemiology (PhD) and in Clinical Research (MS) offer opportunities for
courses in epidemiology, cancer epidemiology, biostatistics, bioinformatics, cancer biology, genetic
epidemiology, immunology, clinical trials/methods, and field research. Further, students have several
unparalleled opportunities for supervised translational and genomic research projects in human, animal, and
in vitro data, study design and development, statistical analysis, and individual and team grant writing.
Predoctoral students are formally admitted to the graduate school PhD program in Epidemiology. The
postdoctoral trainees are drawn from the medical, basic and applied sciences through national advertising and
our Masonic Cancer Center members, and from the cohort of medical fellows in the Department of Pediatrics
who have completed advanced clinical training in pediatric oncology and are embarking on the research
component of their training. Spe‐cial attention is given to recruitment of individuals from underrepresented
minorities. We anticipate that two of our postdoctoral trainees will choose to obtain an MS in clinical research.
Criteria for selection of both pre and postdoctoral trainees include a strong academic performance and a
career orientation toward independent research in an academic, clinical, or public health setting. Each trainee
is guided by at least two senior mentors from complementary disciplines in their research projects. All trainees
participate in courses in pediatric cancer topics and readings in pediatric cancer epidemiology, weekly
pediatric cancer seminar meetings and pediatric tumor conferences, monthly seminars, annual retreats, and
presenters of their own research at national meetings. Postdoctoral students receive additional training in
grant writing/preparation. All receive instruction in the responsible conduct of research. Trainees who graduate
from this program will have the capacity to undertake high impact pediatric cancer research across a spectrum
of disciplines.

Public health relevance
Public Health Relevance Childhood cancer is the leading cause of death due to disease in children in the United States. Childhood cancer survivors, which number over 350,000, face lifelong increased morbidity and mortality. This training program equips researchers and physician-scientists with experience in classical epidemiology, genomic epidemiology, laboratory studies, and clinical investigations relevant to childhood cancer etiology, outcome, and survivorship.